Biomarker Core

SUMMARY BIOMARKER CORE
The Stanford ADRC Biomarker Core works to provide deep-genotyping and deep-phenotyping data to
strengthen the biological evidence for clinical classifications of participants as healthy older controls,
Alzheimer’s disease (AD) spectrum patients, and Lewy body disease (LBD) spectrum patients. To this end the
Core will measures current consensus AD biomarkers such as pTau217 and the Aβ42: Aβ40 ratio in plasma of
all ADRC participants as well as in the cerebrospinal fluid (CSF) of those who agree to lumbar puncture. All
CSF samples will be also sent for the CLIA-approved alpha-synuclein seeding assay (αSyn-SAA), a new
consensus biomarker for LBD. In addition to providing consensus biomarkers for AD and LBD, the Core will
generate a large amount of multiomics data—including proteomics, lipidomics, and glycomics—for discovery
science. All Stanford ADRC participants will have high-coverage (~30x), whole-genome long-read sequencing
data which will allow accurate calling of single nucleotide variants, structural variants and methylation profiles.
The hope is that wide sharing of these data from these deeply-genotyped and deeply-phenotyped ADRC
participants will accelerate discovery science leading to novel biomarkers, novel pathogenic insights, and novel
drug targets. To maximize the impact of these datasets, the Biomarker Core will work closely with the Data
Management and Statistics Core to provide quality-controlled summary data that will be queryable through a
web portal. Raw datasets will be made available through the Alzheimer’s Disease Data Initiative, an NIH-
supported data repository. The Biomarker Core faculty and senior staff will hold quarterly data showcases and
provide training opportunities for scholars in the Research and Education Component as well as trainees and
investigators new to multiomics research. Specific efforts will be made, in conjunction with the Justice, Equity,
Diversity and Inclusion (JEDI) team, to support trainees and investigators from underrepresented in biomedical
research groups in making full use of these data.